Mechanisms of Homeodomain Transcription Factor Specificity

PROGRAM SUMMARY/ABSTRACT:
The goal of my research program is to determine how homeodomain (HD) transcription factors (TFs) that bind
highly similar DNA sequences in vitro specify different developmental outcomes. HD genes constitute one of the
largest groups of TFs in humans with over 200 family members that regulate a wide variety of processes including
anterior-posterior patterning, organogenesis, and cell fate specification. Highlighting their impact on health, HD
genes encode the most disease-associated variants in the Human Gene Mutation Database in comparison to
other TF families. Collectively, over 100 HD genes have variants associated with diseases that impact numerous
organs and tissues. Unfortunately, the identification of disease variants has greatly outpaced our understanding
of their functional impact as hundreds of HD missense alleles have been classified as variants of unknown
significance. Thus, it is imperative to define the underlying mechanisms to elucidate rules governing human
variation and disease. While biochemical and structural studies have provided a wealth of information about how
the HD binds DNA, recent studies revealed many variants cause unexpected changes in DNA binding. These
findings expose three critical knowledge gaps: (1) How do HD proteins with highly similar DNA binding domains
increase their DNA binding specificity to accurately regulate target genes? (2) How do the hundreds of HD
missense variants associated with disease alter HD function? (3) Once bound to DNA, how do HD TFs activate
and repress target genes and what role does the type of binding site play in transcriptional outcomes? To address
these questions, I have assembled a transdisciplinary research team with complementary expertise that includes
biochemical, bioinformatics, structural, cellular, genetic, and genomic approaches. Our team has recently
developed a combined computational and experimental approach to discover that subsets of HD TFs form
cooperative complexes on composite DNA sites with distinct site spacing and orientation requirements. Over the
next five years, our plan is to use an iterative approach of using computational approaches for composite motif
discovery followed by molecular, biochemical, and structural approaches to define the mechanisms underlying
each cooperative complex. Comparative studies between different HDs and disease variants on different site
configurations will provide novel insights into how HD factors gain DNA binding specificity and how disease
variants cause molecular defects that lead to pathogenesis. We will develop new research tools and applications
of high-throughput (HT) DNA binding assays, massively parallel reporter assays, and proteomic approaches to
provide a comprehensive understanding of how binding affinity and cooperativity impact gene regulatory
outcomes and define the co-factors used by different HD proteins to mediate accurate outcomes. Lastly, we will
develop Drosophila and human organoid models that have unique strengths in genetics and genomics,
respectively, to study the DNA binding and transcriptional regulatory potential of HD factors and analogous
disease-associated variants within relevant developmental cell types.

Public health relevance
PROJECT NARRATIVE / LAY ABSTRACT Homeodomain transcription factors regulate many developmental processes, and mutations in over 100 homeodomain genes have been associated with causing a wide variety of developmental diseases and defects. How homeodomain proteins, which largely bind the same DNA sequences, regulate distinct developmental processes is not well understood. The goal of my research program is to use a combination of computational, biochemical, structural, and cellular approaches to discover how the formation of homeodomain transcription factor complexes increases DNA specificity to accurately regulate target genes during development.